Rigorous Research Principles for Practicing Neuroscientists

PROJECT SUMMARY
Advances in technology for measuring neural activity at ever-larger scales and with increasing spatial and
temporal resolution, concomitant with a decrease in costs of data storage, are driving a revolution in
neuroscience. As neural data accumulates worldwide, a new challenge faces the global neuroscience
community: how to make sense of these complex data to drive biological insight and to shed new light on
neurological and neuropsychiatric disorders. This new, data-driven era of neuroscientific research demands
that investigators master rigorous research principles and know when and how to apply these principles.
Accessible resources to develop hands-on experience with these rigorous research techniques are lacking in
neuroscience. To address this current and growing challenge, we propose to develop educational units
focused on specific principles of rigorous research. To reach the largest target audiences - the biologists,
psychologists, and clinicians working directly with neural data - we will assume only a basic mathematics
background and limited familiarity with computer programing, common to those trained in biological sciences.
The proposed educational units will target investigators at all career levels - spanning from the beginning
undergraduate researcher to the established PI - to understand and apply principles of rigorous research to
neural data. Through an interdisciplinary case-study approach, we will use real-world data from neuroscience
to motivate the study and application of rigorous research principles. To engage learners, we will develop
multimedia material combining written text, short video lectures, and computer programming exercises, that
promote hands-on learning of the material. The modular format will provide multiple coherent learning paths
through the online content, and thereby allow personalized learning for individuals with varying quantitative
backgrounds and research interests. The educational unit format will also permit the developed resources to
be widely available, disseminated, and discoverable, and easily integrated into the CENTER framework. The
proposed educational units will prepare researchers with the fundamental skills required for the analysis of
neural data and elevate the general competencies in rigorous research principles across the research
workforce.

Public health relevance
PROJECT NARRATIVE Rigorous research techniques are essential to addressing fundamental questions and challenges in modern neuroscience research. The proposed educational units will elevate competencies in the application of rigorous research principles across the research workforce, with a large potential impact in all areas of neuroscience research, including the nation’s biomedical, behavioral, and clinical research needs.